The Great Diseases: Bridging biomedical career exploration, competency building and mentoring

In 2019 many bioscience and health related jobs are going unfilled, not only because too few STEM degrees
are being granted (not all of these jobs require degrees) but also because adults either lack key competencies
in thinking analytically and solving STEM-related problems or cannot apply them to STEM fields. Moreover,
minority and under-resourced communities are disproportionately under-represented, in large part because
they lack access to role models and information about what the careers entail. High school, where entire
cohorts of the US population gather to learn together for the last time, is an obvious venue in which to develop
these capacities and increase participation from all communities. Our long-standing partnership with teachers
in the majority/minority Boston Public Schools has developed a curriculum for 10th-12th graders that targets
these competencies. Teachers who have been supported in learning to teach these novel concepts are able to
significantly increase student engagement and analytical and problem-solving abilities from a large number of
diverse schools and independent of the gender and ethnicity of the students, fostering their confidence in
learning about health topics. However, this curriculum is not designed to integrate career awareness into
competency building. In this project we aim to capitalize on the partnerships, infrastructure and evaluation
tools we have already deployed successfully to create a new curriculum and professional development model:
It has three phases: (1) We will create and implement new curricula that tightly integrate career awareness
with competency building to improve student self-efficacy and outcomes expectations, critical first steps toward
selecting a bioscience career. The curriculum will also provide extensive teacher professional development
support. (2) We will develop new online dual-enrollment courses in which students can gain college credits
while still in high school. The courses will incorporate with skills and strategies needed for a successful
transition to independent learning environments into cutting-edge biomedical science topics. (3) We will
provide students with financial support so they can participate in our intensive residential college awareness
and readiness program and will optimize their success with near-peer mentor support before, during and after
participation. Once the program has been created and evaluated, we will go on to disseminate the curricula
and teacher support though our existing online infrastructure to reach maximal audiences. The new project is
significant because it integrates teaching high school students critical high-level STEM competencies with
extensive career awareness thereby fostering workforce preparation. It is innovative because it provides a
model for how medical school scientists can interact with teachers to influence curricula, teacher development
and STEM/bioscience workforce participation and because the web-based resource facilitates nationwide
dissemination.

Public health relevance
RELEVANCE TO PUBLIC HEALTH This project is relevant to public health because it directly addresses gaps in the bioscience/medical workforce pipeline, particularly with respect to the participation of minority and under-represented communities. The innovative three-phase program 1) integrates in-school instruction in the high level bioscience competencies required for 21st century careers and extensive exposure to different careers with 2) online dual-enrollment courses that demystify the college experience as well as providing guidance in the skills and strategies needed for independent learning while 3) providing an intensive residential career awareness program with near-peer mentor support. The program includes training for teachers implementing the material and for the near-peer mentors who will interact with the students, and will thus help students master critical health-related subject matter, develop their scientific reasoning skills, health literacy and increases their awareness of science and health care careers so they can make informed career choices.